MDSRC for Next Directions in Muscular Dystrophy Research

Abstract
The Center for Gene Therapy at the Abigail Wexner Research Institute of Nationwide Children’s
Hospital (NCH) hosts a robust and active research community in the muscular dystrophies, with
extensive expertise in unraveling disease pathogenesis and developing new treatment paradigms
that can be translated from the bench to the bedside. We propose an MDSRC with Cores
designed to share this expertise with the Wellstone and broader muscular dystrophy research
communities, with Projects intended to address questions raised or left unanswered by current
therapies, such as microdystrophin gene therapy. Project 1 (PI, Paul Martin, PhD) seeks to utilize
a novel bicistronic AAV vector to both prevent muscle disease and simultaneously build new
muscle function in muscular dystrophy patients with Limb Girdle Muscular Dystrophy 2I (LGMD2I).
Project 2 (PI, Kevin Flanigan, MD) will develop vectors containing U7 small nuclear RNAs
(U7snRNAs) reprogrammed with antisense sequences directed toward splice site or splice
enhance elements to restores highly functional dystrophin expression. Project 3 (PI, Nizar Saad,
PhD) seeks to identify novel circulating biomarkers through the investigation of circulating
extracellular vesicles (EVs) and to develop a new generations of gene therapy that increase
transduction efficiency, dystrophin expression, and reduce the development of humoral immunity
against AAV gene therapies. All three projects make use of the critical resource core, the
Muscular Dystrophy Cell and Serum Banking Core (Director, Nicolas Wein, PhD) by establishing
primary fibroblasts from patients with muscular dystrophies, a critical resource for early therapy
development, while collaborating with Penny Gilbert, PhD, at the University of Toronto, to develop
improved protocols leading to superior reagents for Center Projects. We have a longstanding
dedication to serving as a national training resource, as demonstrated by our Myology Course,
held annually since 2012, and our Training Core (Director, Scott Harper) will expand the number
of attendees and the range of topics covered in the Course, offer individualized career
development guidance to Wellstone Fellowship trainees, and develop new curricula of benefit to
the community. Our Administrative Core will implement a meaningful community outreach
program and develop a highly functional MDSRC website to provide access to the muscular
dystrophy community. Altogether, our longstanding efforts and the highly collaborative
multidisciplinary environment of our two institutions will be synergized by a MDSRC that leverages
existing structures and collaborations, and develops outward-facing resources of benefit to the
broader Wellstone and muscular dystrophy research communities.

Public health relevance
NARRATIVE The Research Institute at Nationwide Children’s Hospital proposes a Muscular Dystrophy Specialized Research Center that builds upon our extensive expertise in therapeutic development, including first-in-human gene therapies, with a Shared Resource Core that develops critical patient-derived reagents for testing of new therapies, a Training Core that builds upon our nationally-recognized myology training program, and Projects intended to develop the next generation of therapies beyond microdystrophin gene therapy.